Stress granules in virus infections

Stress granules (SG) are non-membranous, phase-separated complexes of stalled mRNA, translation factors
and RNA binding proteins that are formed transiently in the cytoplasm in response to diverse stress signals,
including viral infections. SG formed during viral infection, antiviral stress granules (avSG), are distinct from
canonical SG in that they recruit antiviral proteins and components of signaling pathways to function as a
platform to mount an effective antiviral response. However, the composition, temporal changes and function of
avSG during viral infections are still poorly understood. The dynamic nature of SG suggest that host cells use
avSG as a signaling hub for antiviral defense. On the other hand, viruses have evolved mechanisms to
antagonize SG formation and repurpose SG to facilitate replication highlighting an important role in viral
pathogenesis. How the stress-specific differences in SG composition, assembly and dynamics impact
the outcome of viral infections remains unclear and represents a critical gap in our understanding of
signaling events and host-virus interactions. Our recent work has highlighted a role for avSG as a platform
for the activation of pattern recognition receptors (PRRs) by dsRNA pathogen associated molecular patterns
(PAMPs) and subsequent interferon (IFN) response during viral infections. DsRNAs produced during viral
infections serve as PAMPs to stimulate interferon (IFN) production by binding the cytosolic Rig-like helicases
(RLHs), endosomal Toll-like receptors (TLRs), dsRNA-dependent protein kinase (PKR) or 2’-5’oligoadenylate
synthetase (OAS). Furthermore, virus infection induces degradation of viral and cellular RNAs by the activity of
interferon-induced endoribonuclease, RNase L. We have recently shown that dsRNA products of RNase L
activity function as PAMPs and activate PKR, phosphorylate eukaryotic translation initiation factor-2 (eIF2)
to suppress translation and induce avSG formation. Our results demonstrate that avSG assembly provides a
platform for efficient interaction of RNA ligands with PRRs to enhance interferon production and antiviral effect.
Our overarching hypothesis for this proposal is that composition, assembly and disassembly of avSG
change during viral infection to allow host cells to respond and clear infection by limiting damage. In
preliminary studies we show that activation of RNase L induces avSG formation marked by SG protein, G3BP1
and contain antiviral proteins Rig-I, PKR, OAS and RNase L. We developed a novel method to purify avSG
and biochemically characterized protein-protein interactions in avSG that will be used in this proposal. We will
test our central hypothesis with the following specific aims. Aim 1: To determine stress-specific differences in
SG composition in canonical SG and avSG, Aim 2: To determine the physiological role of dynamic change in
avSG composition in virus infections. Completion of these aims will allow us to build on the advances in
purifying avSG to dissect the antiviral role of SG by following the dynamics of assembly or disassembly and
analyzing the avSG composition to provide correlation of stress response pathways and innate signaling.

Public health relevance
Project Narrative Virus infection activates stress response pathways in host cells by forming stress granules. The composition and assembly/disassembly of antiviral stress granules change during the course of viral infection to mount effective immune response. Uncovering the role of antiviral stress granules in the outcome of virus infections will identify novel therapeutic targets.